IGF::OT::IGF RELAPSE PREVENTION MOTION AND VOICE VIDEO GAME; POP: 9/2/2014-9/1/2016; N44DA-14-4419 SBIR Phase II (Topic 150) Modification to Remove IT Risk Assessment requirements.

Examining the effects of Motion and Voice Video Game on Relapse prevention in drug addicted youth.